UNC Center for AIDS Research Core I International

PROJECT SUMMARY/ ABSTRACT – INTERNATIONAL CORE (CORE I)
The UNC CFAR International Core facilitates translational, clinical, epidemiological, behavioral, and health
services research between our North Carolina-based members and international investigators at the center of
the epidemic. We connect UNC, FHI360, and RTI scientists to critical research populations overseas and
connect in-country scientists to collaborations and training opportunities in North Carolina. The Core provides
critical administrative and logistical support services to CFAR members working internationally, with particular
attention to early stage investigators and faculty who are newly expanding their work into a global setting. Among
the most important of the services provided by Core I is the management of international IRB relationships, which
is centralized through a dedicated international regulatory affairs unit. This critical unit manages all aspects of
research ethics and regulatory submissions for all international HIV research activities at UNC.
The International core also serves as a coordinating body for international HIV-related research training activities.
Our CFAR has a total of 10 active NIH training grants with major HIV/AIDS components. In the coming funding
cycle, we will redouble our efforts to enhance the collective impact of these programs through regular convening
of their leadership, sharing key resources, and coordinating trainee placement. Toward this end, we are
proposing a new Co-Director for Training who will be primarily responsible for connecting trainees to appropriate
CFAR mentorship and assisting them in developing new research proposals to our developmental Core and to
the NIH.
Other key functions of our core include ensuring that our CFAR’s international HIV/AIDS research is in line with
local priorities. This will be done through establishing a new internal advisory board comprising membership from
each of the 5 “focus countries” in which we work. The Core I leadership will also ensure engagement of local
investigators in all aspects of our work, support dissemination of key findings to investigators and thought leaders
at our international sites, and facilitate south-to-south exchange of research capacity. Since laboratory capacity
is so important to research in international settings, our core has created a laboratory support unit based at our
flagship lab site in Malawi. Key personnel from this laboratory are available to assist other HIV research sites in
the deployment of new assays, development and monitoring of quality assurance procedures, preparation for
monitoring visits, and troubleshooting of lab operational problems.
Finally, Core I will continue to promote external collaboration through active participation in ongoing intra-CFAR
activities and through linking our membership with other NIH-sponsored networks, such as ACTG, MTN,
IMPAACT, HPTN, and HVTN.